PRemature Infants, Moms, and the Social determinants of health - an Epigenetic Investigation (PRIMS-EI)

PROJECT SUMMARY/ABSTRACT:
Preterm infants and their mothers are frequently exposed to toxic stress resulting from the neonatal intensive
care unit (NICU) environment. Toxic stress develops when stress becomes excessive and causes prolonged
activation of biologic stress responses, potentially disrupting brain circuitry and normal physiologic systems.
Toxic stress increases the risk for alterations in stress responses and epigenetic alterations in both preterm
infants and their mothers.8 Alterations in the glucocorticoid-related gene NR3C1 and the promoter region of the
serotonin promoter gene SLC6A4 have been linked to toxic stress in both preterm infants and women during
the perinatal period.4,8 Infant toxic stress from the NICU environment arises from repeated and aberrant
exposures to excessive light, sound, and painful stimuli during a period of critical neurologic development.
Mother experiences of toxic stress result from an often-unexpected preterm birth, alterations in parental role
attainment, infant illness, and the sights and sounds of the NICU.9 This toxic stress must be considered in the
context of the maternal social determinants of health (SDoH) as early life stress is directly linked to the built
and social environment of their mothers.10 Despite this, the mechanisms connecting infant toxic stress to
maternal factors remains ill-defined. Importantly, the investigations accounting for a possible dyadic
relationship between the preterm infant and mother are nonexistent. Although the relationship between SDoH
and epigenetic changes has been documented, there remains a critical need to identify the biomechanisms
responsible for connecting the dyads’ structural and intermediaries SDoH with toxic stress from the NICU
environment and the resulting physiologic adaptations and disruptions. The purpose of this study is to
delineate the impact of maternal SDoH and toxic stress from the NICU environment for preterm infants and
their mothers. In this descriptive, longitudinal study, we will enroll 80 preterm infants (< 32 weeks gestation)
and their birth mothers. The primary aim is to evaluate how maternal structural and intermediary SDoH and
toxic stress from the NICU environment are associated with alterations in methylation of NR3C1 and SLC6A4
in preterm infants and their mothers. The secondary aim is to evaluate whether toxic stress moderates the
relationship between maternal SDoH and methylation of NR3C1 and SLC6A4. Finally, we will explore preterm
infant and maternal DNA methylation for concordance. Analyses will include descriptions of DNAm changes,
Actor-Partner Interdependence Modeling, and general linear mixed model development. The results from this
study will provide much needed information regarding the cumulative impact of toxic stress from the NICU
environment and will guide future development and testing of target stress reducing interventions in this
vulnerable population. The proposed research is feasible and advance my training goals and help guarantee
the success of my research career.

Public health relevance
PROJECT NARRATIVE This study evaluates the cumulative effect of toxic stress from the neonatal intensive care unit (NICU) with maternal social determinants of health in preterm infant and maternal dyads. Measures of epigenetic alternations serve as a robust indicator of biologic changes secondary to toxic stress. These data are vital for the development and testing of much needed targeted stress reducing interventions that will improve long-term health and development in vulnerable dyads requiring NICU hospitalization.